Targeting Protease Activated Receptor 1 for Repair of the Injured Spinal Cord

PROJECT SUMMARY/ABSTRACT
Secreted serine proteases are abundant in the intact CNS and become deregulated by injury and disease, yet
we lack knowledge regarding their physiological functions and contributions to pathology. Several years ago, the
discovery of a set of enzyme-activated G protein-coupled receptors, the Protease Activated Receptors (PARs),
led to a new conceptual framework for understanding the physiological impact of proteases. PARs permit
activating enzymes to signal in a hormone-like fashion to modulate key cellular functions, but when overactivated
can contribute to pathology. The PI’s team recently discovered that mice with global PAR1 gene knockout exhibit
significant improvements in locomotor recovery after spinal cord injury (SCI). Functional improvements were
accompanied by reductions in inflammation and astrogliosis and improvements in the appearance of myelin and
axons, all integral substrates to support restoration of function. We also documented that CNS injury relevant
proteases, such as thrombin and kallikrein 6 elicit Ca2+, MAPK and STAT3 signaling linked to neuroinflammation
and pro-injury responses across neurons and neuroglia in a PAR1-dependent manner. Together, these studies
highlight the likely multifactorial roles played by PAR1 in key cellular and molecular events positioned to govern
outcomes after SCI. These findings also highlight the potential to target PAR1 for neural protection and repair.
Despite these encouraging findings the cellular mechanisms by which blocking PAR1 improves recovery after
SCI have not been defined and this knowledge gap hampers progress towards translation of existing FDA
approved and orally bioavailable PAR1 small molecule inhibitors. Additionally, whether blocking PAR1
therapeutically at acute or chronic time points after SCI are both capable of improving neural recovery is
unknown. Based on recently published findings, taken with new preliminary results, we propose 3 integrated
Aims to test the Central Hypothesis that PAR1 is an essential regulator of reactivity across the microglial-
astrocyte compartments and can be selectively blocked to improve glial-neuronal trophic coupling,
neuroprotection and repair after SCI. In Aim 1, we will determine the impact of pharmacologic PAR1 inhibition
initiated at acute or chronic time points after injury on signs of neuroprotection, neural repair and recovery of
sensorimotor function and use ribosomal mRNA capture techniques to document cellular and molecular
mechanisms engaged across the astroglial, microglial/monocyte and neuron compartments. In Aim 2, we will
determine whether conditional deletion of PAR1 selectively in astrocytes, microglia or peripheral monocytes is
sufficient to enhance recovery. In Aim 3, we will use glial-neuron co-cultures as bioassays to establish PAR1-
regulated glial-neural trophic coupling mechanisms relevant to neuroprotection and repair. The studies proposed
address key mechanistic questions regarding the functional roles of PAR1 in neural injury and will provide new
information needed to optimize therapeutic targeting strategies for recovery of function.

Public health relevance
PROJECT NARRATIVE There are more than 300,000 individuals living with disabilities associated with traumatic spinal cord injury (SCI) in the United States, with approximately 17,000 new cases each year, yet there are no clinically approved treatments to significantly improve outcomes. We have determined that a highly druggable cell surface receptor, the thrombin receptor, can be blocked to improve functional outcomes in experimental SCI models. The proposed experiments will move these findings closer to clinical translation by establishing the efficacy of therapeutic targeting with small molecule inhibitors, providing essential insights into the mechanisms involved and determining when after SCI receptor targeting is likely to be most effective.